PROGENITOR CELLS RESPONSE TO NITROUS OXIDE AND HUMAN ANTIBODIES

The purpose of these investigations is to employ bone marrow progenitor cells in experimental situations that (1) generate increasing amounts of nitric oxide to measure the effects of nitric oxide on short-term colony growth and (2) involve the identification of new antibodies to human hematopoietic stem and progenitor cells.